Persistent Impacts of Adolescent THC on Microglial Function and Opioid Addiction Risk

Project Summary
Adolescent cannabis use has been linked to negative long-term outcomes in humans, including increased rates
of experimentation with “harder” drugs like opioids later in life. Yet these associations cannot be tested causally
in humans, so animal studies showing that adolescent THC exposure (adoTHC) indeed causes developmental
disruption of reward and cognition circuits are notable and potentially alarming. Here we employ a well-
characterized, translationally-oriented adoTHC exposure model in rats to examine how opioid-addiction relevant
behaviors are altered, and to uncover novel brain mechanisms by which these behavioral changes may manifest.
Notably, microglia, the resident immune cells of the brain, are increasingly being recognized for their key roles
in neurodevelopment, including in adolescence. In pursuit of a mechanistic understanding that can inform novel
interventions or strategies for opioid addiction, my project examines the effects of adoTHC exposure on
microglia, and how these changes may impact opioid drug seeking behavior.
I employ translationally relevant behavioral models of opioid addiction in rats to fully characterize the adoTHC-
induced pro-opioid phenotype, and employ both hypothesis-generating RNA sequencing approach, as well as
an experimental microglial “resetting” approach to test the causal relevance of microglia in the observed pro-
opioid behavioral phenomena seen in males and females.
During the F99 phase of this award, I will replicate and extend my findings, and obtain training and new data
employing RNA sequencing of FACS-isolated microglia in prefrontal cortex. The proposed training will
facilitate my transition to a competitive postdoctoral position focused on in vivo imaging and monitoring of
microglia, building upon my current expertise in addiction behavioral models. My sponsors will be instrumental
in helping me build skills in experimental design, guided analyses support, scientific communication, and
grantsmanship. They will also guide me in finding a postdoctoral training environment focused in
neuroimmunology aligning with my long-term research and career goals. Altogether, the F99/K00 award serves
as an invaluable asset in propelling me on a trajectory towards becoming a tenure-track addiction behavioral
neuroscientist.

Public health relevance
Project Narrative Early cannabis use is associated with later use of harder drugs like opioids in humans, and rodent studies have suggested that THC may cause changes in opioid addiction-relevant brain circuits that could underlie this association. Microglia, the brains’ immune cells, contribute significantly to brain development by influencing neural circuit remodeling and rewiring, and they respond to developmental insults like THC as well as to adulthood opioid drugs. Here we study the causal roles of microglia in long-lasting pro-opioid effects, help uncover novel microglial biology with relevance to addiction, and attain training in RNA sequencing and bioinformatics, writing, and career development positioning me well for a career in addiction neuroimmunology.